American Academy of Audiology's Academy Research Conference (ARC) 2022-2024

Project Summary / Abstract The American Academy of Audiology’s Academy Research Conference (ARC) 2022 – 2024 will be the 14th – 16th meetings of this annual translational research conference that was launched in 2009. ARC provides clinicians and researchers a unique opportunity to ? together ? take a “deep dive” into a clinically important research area. Conferences are equally designed for two primary target audiences: audiologists who wish to improve their clinical practices and gain a better understanding of cutting-edge research; and scientists who want to keep abreast of recent developments in translational research and engage in conversations with clinicians that may spur collaborative relationships and inform future work. Post-doctoral fellows and doctoral students in audiology and hearing sciences also have the opportunity to join the thought-provoking discussions at ARC, with some competitively selected to make poster presentations and oral presentations as a means of encouraging our early- career scientists. In keeping with the mission of ARC to make research available to practitioners, the conferences are held each year on the opening day of the American Academy of Audiology’s national convention and exposition, which draws an audience of over 5,000 audiologists, scientists, doctoral students, and representatives from a wide range of industries, organizations, and other agencies of interest to the profession of audiology. ARC 2022 will convene on March 30, 2022 in St. Louis, Missouri, with a program on Age-Related Hearing and Balance Decline. This program exemplifies ARC’s

Public health relevance
Project Narrative The American Academy of Audiology’s Academy Research Conferences (ARC) are intended to bridge the gap between clinical practice and academic research by engaging audiologists, scientists, and students in translational presentations and discussions on clinically significant research topics. ARC 2022’s program on Age- Related Hearing and Balance Decline exemplifies ARC’s public health relevance. This topic addresses an area of auditory science that significantly impacts the clinical care of aging adults and is posed to transform the broader hearing healthcare field. Hearing loss is one of the most common conditions associated with aging, impacting 30 – 50% of individuals over 65 years of age. Emerging science associates age-related hearing loss with cognitive decline, highlighting the importance of understanding this area of clinical research. Additionally, vestibular loss is a concern for aging individuals as it increases the risk for falling. Falls are associated with considerable morbidity and mortality and better understanding of this heterogeneous group will improve our ability to reduce fall risk. Given the prevalence of hearing and vestibular loss in the general population, there is substantial need to provide the latest aging research as it relates to clinical practice. ARC 2022 will bring together scientists and clinicians to initiate collaborative opportunities to further our understanding of aging in the clinical population. ARC 2023 and ARC 2024 will also address critical public health issues for patients, with focus on Next Generation Inner Ear Therapies and Advances in Cochlear Implantation.